Development of NLRP3 inhibitors for HIV-associated neuroinflammation in cocaine use.

ABSTRACT
Despite the advances in antiretroviral therapy (ART) and its widespread use, cognitive impairment is commonly
seen in HIV-1-infected patients. A salient feature of the HIV-1 infection is the initiation and maintenance of
chronic inflammation which underlies a number of co-morbidities. HIV-associated neurocognitive disorders
(HAND) represent a most common comorbidity in HIV patients and involves a spectrum of cognitive, motor,
and/or neurological issues. Substances of abuse, such as cocaine, aggravate the CNS pathogenesis even in
patients receiving ART, with neuroinflammation playing the central role in this comorbidity. Given the
widespread occurrence of substance abuse in HIV patients, therapies that specifically target
neuroinflammation in this patient population remains an urgent and unmet challenge. Nucleotide binding
domain of the leucine rich repeat pyrin domain containing protein-3 (NLRP3) inflammasome has emerged as a
druggable target for the management of HIV-1-associated neuropathologies, but optimal drug candidates have
not been designed yet. The NLRP3 inflammasome is shown to be activated in response to a wide array of
pathogen- and danger-associated molecular patterns (PAMPs and DAMPs respectively). Activation of the
NLRP3 inflammasome in turn, stimulates the activity of caspase-1 and results in the release of pro-
inflammatory cytokines, such as interleukin-1β (IL-1β) and IL-18, ultimately causing neuronal pyroptosis and
death. Disruption of NLRP3 signaling was reported to display beneficial effects in the transgenic mouse models
of neuroinflammation. Our recent studies identified a small molecule, AMS-17, that thwarted the NLRP3
activation in N9 microglia both in vitro and in vivo. AMS-17 was well-tolerated by the microglial cells and did not
adversely affect microglial viability. This proposal is focused on developing computationally-guided structural
changes in AMS-17 to improve its biological activity and maintain low toxicity. Aim 1 described in this proposal
is focused on the computer-assisted design, synthesis and chemical characterization of AMS-17 analogues.
Aim 2 will involve in vitro and in vivo screening of the novel analogues developed in Aim 1. The in vivo studies
will be performed in HIV-infected humanized mice treated with cocaine, thus modeling the disease in people.
The proposed studies are highly significant since they will provide new therapeutic options to minimize HIV-
associated neurocognitive dysfunction in substance abuse. The proposal incorporates expertise in the area of
synthetic medicinal chemistry (Dr. Kulkarni), computational chemistry (Dr. Hevener) and biological screening
(Dr. Bukrinsky). Additionally, Dr. Mocchetti will provide his expertise in the area of animal models of cocaine in
HIV. The proposal builds on our previous research and is fully consistent with the goals of this RFA.

Public health relevance
Narrative Inflammation plays a pivotal role in the development of HIV-associated comorbidities, including HIV-associated neurocognitive disorders (HAND). The use of substances of abuse, such as cocaine, worsen the neurological outcomes in HIV patients. We propose to develop novel NLRP3 inhibitors that will minimize the neuroinflammation in HIV patients abusing cocaine.